INFUSION OF BONE MARROW MESENCHYMAL STEM CELL

The purpose of this study is to demonstrate that it is both safe and feasible to take a small sample of human marrow and isolate and geometrically expand the mesenchymal stem cells (MSC) and infuse these cells back into the patient. Part II will use MSC to augment marrow reconstitution and test the hypothesis that MSC infusions given along with autologous marrow can speed reconstitution of peripheral blood cells.